Roles of resident macrophages in salivary gland development, homeostasis, regeneration, and function restoration after radiotherapy

Project Summary
The long lasting decrease of saliva secretion, also called dry mouth, is common in patients
treated with radiotherapy for head and neck cancer. This side effect significantly impairs
the quality of life of affected patients and is difficult to remedy. The applicant’s recent work
revealed that macrophages abundant in salivary glands are sharply damaged by
radiotherapy, and their recovery is required for restoring saliva secretion. The goals of this
proposal are to determine the roles of local macrophages in the development,
maintenance and regeneration of salivary glands, and how these cells respond to radiation
and restore salivary function damaged by radiation. To achieve these goals, this project
will trace the origin of local macrophages under conditions mentioned above, determine
effects of removing these cells on salivary function, and pinpoint which molecules are
responsible for the damage of these cells by radiation and for the recovery of salivary
function damaged by radiation. Completion of this project will reveal vital roles of local
macrophages and their products in the maintenance of saliva secretion, and form a basis
for developing novel and feasible approaches to treating dry mouth caused by
radiotherapy.

Public health relevance
Project narrative Radiotherapy for head and neck cancer commonly results in the irreversible and severe decrease of saliva secretion that impairs the quality of life of patients remarkably. The goals of this proposal are to determine novel mechanisms of this side effect related to local macrophages and to develop corresponding approaches for restoring radiotherapy- damaged salivary gland function. The success of proposed studies will improve the recovery of saliva secretion and consequent quality of life in head and neck cancer patients treated with radiotherapy.